National Xenopus Resource Center

Project Summary
This grant supports a project to purchase equipment specifically for cryopreservation, which will allow the
National Xenopus Resource (NXR) to efficiently create essential cryopreserved stocks of its 400 different
strains. This equipment is needed to help the NXR cryopreserve sperm in special straws. Without
cryopreserving our stocks there is a risk that they can lost should something happen to the live frogs. In
addition, cryopreservation will help alleviate space constraints in the NXR.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research, including cell biology, development, neurobiology, physiology and signal transduction, achievements that are supported by having a centralized National Xenopus Resource for raising and distributing animals and disseminating the most current technology to the research community. In each of these areas research has led to significant insights about the causes of human diseases, including cancer, birth defects, diabetes and neurological disease, and provided key underpinnings for the field of regenerative medicine.